WaNPRC Macaca nemestrina SPF Breeding Colony

PROJECT SUMMARY - OVERALL
The goal of this project is to maintain and enhance the specific pathogen free (SPF) pigtail macaque (M.
nemestrina) breeding colony at the Washington National Primate Research Center (WaNPRC). This colony is
the largest domestic breeding colony of M. nemestrina and is the primary source of this important animal model
for HIV/AIDS studies and other types of biomedical research in the United States. M. nemestrina have unique
immunological, genetic, behavioral, anatomical, and physiological characteristics that make them an essential
model in a number of areas of research related to HIV/AIDS. Specific pathogens (SIV, SRV, STLV-1, McHV-1)
are a threat to animal or human health or interfere with research and must be excluded to optimize nonhuman
primate research models. In this proposal, we discuss how we will maintain and enhance the WaNPRC SPF M.
nemestrina breeding colony to provide animals of the highest quality to meet research needs. Breeding and
maintenance of the SPF breeding colony, including financial sustainability, are described in Core 1, Husbandry
and Management Core. The viral testing that is performed to ensure that the colony remains SPF is described
in Core 2, Viral Testing Core. Genetic management and genotyping animals for parentage and major
histocompatibility complex alleles as well as discovery of novel animal models are described in Core 3, MHC
Genetic Typing Core. The SPF M. nemestrina colony serves as a national resource, providing animals to
HIV/AIDS researchers across the United States, with priority given to NIH-funded investigators.

Public health relevance
PROJECT NARRATIVE - OVERALL The pigtail macaque (Macaca nemestrina) is a critical resource for nonhuman primate models of human diseases, particularly HIV/AIDS. The goal of this project is to increase the availability and improve the characterization of this precious resource for the biomedical and behavioral research community.